The role of Selenoprotein I in mitigating neurodegeneration.

Selenoprotein I (SELENOI) is a poorly characterized enzyme that depends on adequate dietary selenium for
expression and has been shown to catalyze the final reaction of the CDP-ethanolamine branch of the Kennedy
pathway within the endoplasmic reticulum membrane. These pathways depend on SELENOI for efficient
synthesis of phosphatidylethanolamine (PE) and plasmenyl PE, which are important phospholipids in cellular
membranes. Although present in various cell-types throughout the body, PE and plasmenyl PE are particularly
enriched in central nervous system (CNS), where they comprise 45% of total membrane phospholipids.
Plasmenyl PE is the predominant ethanolamine phospholipid in brain, with highest levels detected in white
matter, and contains a vinyl ether bond in the sn-1 position that is preferentially targeted by reactive oxygen
species. In this manner, plasmenyl PE acts as an important antioxidant by preventing the peroxidation of
polyunsaturated fatty acids in membrane phospholipids that can trigger ferroptosis (peroxidated diacyl PE is a
particularly effective executioner of ferroptosis). In humans, rare mutations in SELENOI lead to hereditary
spastic paraplegia (HSP), a neurodegenerative condition affecting upper motor neurons characterized by
impaired functionality of the lower limbs. The current understanding of the mechanisms governing
PE/plasmenyl PE metabolism in brain is limited, in large part due to a lack of representative mouse models that
allow mechanistic studies to be conducted. Our Multiple Principal Investigator (MPI)-led research team has
developed a unique mouse model for mechanistic studies that will utilize our expertise in selenoprotein
biochemistry and neurobiology to generate fundamental new knowledge about SELENOI function in the CNS.
In particular, we have developed a unique mouse model in which SELENOI deletion is restricted to the CNS,
thereby circumventing the embryonic lethality caused by constitutive SELENOI KO in mice. Our preliminary
studies have revealed striking behavioral deficits that parallel those reported in humans with rare loss-of-
function SELENOI mutations. This project will address the following specific aims: 1) Identify and characterize
the behavioral and neuropathological alterations elicited by CNS-specific KO of SELENOI in mice; 2)
Determine the cell-type specific contribution of SELENOI to phospholipid synthesis, ferroptotic vulnerability,
and myelination in vitro using primary neurons and oligodendrocytes. The anticipated outcomes of these
experiments are: 1) identification of the behaviors, brain regions, and cell types negatively impacted by
SELENOI deficiency, 2) discernment of the influence of SELENOI upon PE/plasmenyl PE metabolism in brain,
and 3) determination of whether SELENOI alters sensitivity to ferroptosis. This work will provide mechanistic
insight not attainable with human samples and will lay the framework for future studies investigating the
temporal and cell-type specific role of SELENOI in brain.

Public health relevance
PROJECT NARRATIVE We have generated a novel mouse model to uncover an important role for selenoprotein I in preventing neurodegeneration and central nervous system impairments. The goal of this project is to determine the precise role this protein plays in promoting healthy neurodevelopment due to its role as an enzyme that contributes to the generation of protective phospholipids.